What Drives Poor Care for Child Diarrhea?: A Standardized Patient Experiment

PROJECT SUMMARY/ABSTRACT
Diarrhea is the second leading cause of death for children around the world. This is true despite the fact that nearly all
such deaths could be prevented with a simple and inexpensive solution: oral rehydration salts (ORS). Private health care
providers, who treat the majority of childhood illness in low- and middle-income countries (LMICs), are particularly
unlikely to dispense ORS to children with diarrhea. Instead, providers often dispense antibiotics inappropriately.
Recognizing this significant challenge, several international organizations (including USAID) have invested heavily in
trying to increase ORS dispensing in the private sector. In the absence of evidence on why ORS is so inconsistently
dispensed by private providers, however, several interventions to promote private sector ORS dispensing have been
ineffective. Clearly, a critical and urgent next step is to examine the key drivers of underprescription of ORS and
overprescription of antibiotics in the private sector in order to inform efforts to improve diarrhea care. In this study, we
examine several leading explanations for poor quality of care for child diarrhea in the private sector. First, patient
preferences for ORS alternatives (e.g., an antibiotic) could be driving underprescription of ORS. We will identify the
causal effect of patient preferences (Aim 1) by having anonymous standardized patients (SPs) pose as caretakers of
children with diarrhea and express different (randomly assigned) preferences for treatment (ask for ORS, ask for
antibiotics, or let provider decide). Second, private providers could be responding to financial incentives to sell more
profitable alternatives to ORS (e.g., an antibiotic). To estimate the causal effect of financial incentives (Aim 2), we will
instruct a subset of SPs to inform providers that they can get discounted treatments at a relative’s drug shop. This
eliminates the provider’s financial incentive to recommend a given treatment and allows us to estimate the effect of such
incentives. Finally, private providers might not directly distribute ORS or could have frequent stock-outs. To estimate the
causal effect of stock-outs (Aim 3), we will randomly assign half of the providers to receive a three-month supply of ORS.
This generates exogenous variation in stock outs and thus enables us to isolate the causal effect of stock outs on ORS and
antibiotic prescribing. Combining, (a) causal estimates of the impact of each factor on prescribing, and (b) population
estimates of the prevalence of each factor, will allow us to estimate the population level impact of implementing
interventions that address each factor (Aim 4). This study will provide the most comprehensive evidence to date on why
one of the most important health technologies in history is often not prescribed. The results will inform the design of
interventions aimed at increasing ORS dispensing and reducing antibiotic dispensing. If such interventions are targeted
appropriately, millions of young lives could be saved.

Public health relevance
PROJECT NARRATIVE Diarrhea is the second leading cause of death for children around the world, although nearly all of these deaths could be prevented with an inexpensive and simple treatment: oral rehydration salts (ORS). Many children with diarrhea do not receive ORS when they seek treatment and this study uses a field experiment to examine why this occurs. We will use anonymous standardized patients combined with a randomized ORS supply intervention to isolate the causal effect of several potential reasons for why children do not receive ORS when they seek care: 1) caretakers prefer ORS alternatives, 2) providers have a financial incentives to prescribe ORS alternatives, and 3) ORS is often out of stock.